FLUORESCENT PTERIDINE NUCLEOSIDE ANALOGS

"Fluorescent pteridine-based nucleoside analogs that can be site-specifically incorporated into DNA oligonucleotides through a phosphodiester linkage have been developed and patented. The fluorescence properties of a series of these compounds have been characterized and potential applications are being investigated. These new fluorophores are promising probes for the study of protein/DNA interactions, because they are not attached to DNA externally and they do not appear to disrupt the tertiary structure of DNA. Rapid fluorescence-based assays for HIV-1 integrase and alkylguanine-DNA-akyltransferase have been developed, and the potential utility of these fluorophores as hybridization probes has been patented and is under investigation."